Arsenicals in infant foods

PROJECT SUMMARY
The purpose of this supplement (PA-21-071) is to “enhance the diversity of the research workforce by recruiting
and supporting students….including those from groups that have been shown to be underrepresented in health-
related research”. Aarthi Annamalai will be a trainee on the on-going NIEHS project (R03ES034194:”Evaluation
of the timing and duration of low level dimethylarsinic acid exposure to its fate, metabolism, and development of
neurodevelopmental and neurodegenerative biomarkers). Ms. Annamalai is a female, first generation
Malaysian-American student, currently enrolled in the Microbiology program at Texas Tech University. Ms.
Annamalai will graduate in Spring 2024 and aims to start her medical degree program after graduating with her
BS. In the proposed research plan, which is a reasonable extension of the parent project, Ms. Annamalai will
evaluate total arsenic and arsenic species prevalent in infant foods under the supervision of Drs. Amrika
Deonarine and Jeremy Bailoo (PIs of the parent grant). The project will extend the scope of the parent grant from
an in vivo animal model to a comprehensive evaluation of arsenic speciation of commonly consumed infant foods
identified in the FDA’s Total Diet Study. Ms. Annamalai will utilize her knowledge of developmental biology and
environmental chemistry to solve real problems in environmental toxicology in relation to pathological outcomes
in childhood. Ms. Annamalai will have the opportunity to present her work at a national conference and will learn
how to write and publish a research article. Through this project, Ms. Annamali will learn critical thinking, develop
experimental skills, and conduct independent research. The entire training program will provide a platform for
her to address contemporary medical issues as a consequence of exposure to environmental toxins, such as
arsenic.